Stroke Disordered Breathing and its Impact on Cognitive Decline in Aging, Alzheimer's Disease and Cerebral Amyloid Angiopathy

PROJECT SUMMARY
Stroke is the leading cause of long-term disability in the United States. The major contributors to stroke-related
disability are motor and cognitive deficits, which tend to worsen over time, especially in aged individuals. Stroke
also accelerates other age-related diseases, such as Alzheimer’s disease (AD) and cerebral amyloid angiopathy
(CAA). The prevalence of respiratory dysfunction is high in stroke patients and it impairs recovery and increases
mortality. Studies investigating the mechanisms underlying stroke-induced respiratory dysfunction (SIRD) are in
their infancy. Even less is known about how disordered breathing can influence motor and cognitive outcomes
after stroke, especially in aged individuals that have other features of neurodegeneration, including cerebral
amyloid. There are currently no animal models of post-stroke respiratory dysfunction, limiting our ability to
investigate the mechanism of respiratory dysfunction after stroke or to develop interventions to stabilize breathing
to improve cognition. Our preliminary data shows that stroke leads to the development of periodic breathing and
apnea in mice, the severity of which is correlated with both mortality and progressive cognitive decline in
survivors. Stroke is also very common in AD and CAA patients and SIRD may contribute to cognitive decline in
AD and CAA, increasing amyloid burden. Treatment of stroke disordered breathing may decrease Aβ burden
and reduce neurodegeneration and cognitive decline in AD and CAA patients with vascular disease. We have
recently discovered that stroke induces astrogliosis in brain areas remote from the infarct, including
chemoreceptor areas of the brainstem and reducing gliosis specifically in brainstem improves SIRD and
cognition. Mechanistically, we will determine the cellular source (likely astrocytes at the neurovascular interface),
the molecular mediators (likely transforming growth factor β, TGFβ), and the physiological contribution of this to
the development and progression of SIRD and cognitive decline. We have developed an animal model of post-
stroke respiratory dysfunction that recapitulates the physiology seen in stroke patients and is tightly linked to
post-stroke cognitive function. We will now investigate sex differences in this model and investigate if stroke
accelerates cognitive decline in transgenic mice that develop AD or CAA. Finally we will determine the
mechanisms responsible for stroke-induced respiratory pathophysiology and will attempt to develop therapeutic
approaches to stabilize breathing and enhance recovery of cognitive function. Our central hypothesis is that the
severity of disordered breathing correlates with cognitive and motor decline after stroke in wild-type, AD and
CAA mice and that this is secondary to widespread age-enhanced astrogliosis, leading to impaired
chemoreception and progressive apnea. The proposed work will determine how stroke affects control of
breathing in “normal” aging, in AD and in CAA, and whether treatments designed to improve this respiratory
phenotype reduce disease progression.

Public health relevance
PROJECT NARRATIVE Stroke-induced respiratory dysfunction is a common sequelae of stroke that contributes to increased cognitive impairment and mortality, yet the cellular and molecular basis of stroke-induced respiratory problems are unknown. Stroke is also common in Alzheimer’s disease (AD) and cerebral amyloid angiopathy (CAA) patients. This project will establish an aged mouse model of ischemic stroke that can be used to explore both the physiology of post-stroke respiratory dysfunction and to evaluate the efficacy of treatments that target breathing to improve cognitive function in stroke, in AD and CAA patients.